Investigation of the design, structure and mechanism of Mena protein interaction inhibitors

Project Summary/Abstract
Cancer metastasis depends on coordinated cytoskeletal processes induced by a characteristic change in
expression of specific motility and actin-regulatory genes. Mena, a member of the Ena/VASP family of actin
regulatory proteins, is highly upregulated in invasive cancer cells. The Ena/VASP proteins localize to actin-based
assemblies via their structurally similar EVH1 domains which bind to short linear motifs (SLMs) in other proteins.
Mena is integral to motility pathways that are characteristic of invasive cancer cells. An invasion-associated
splice variant of Mena, MenaINV, has far more potent effects on metastasis than Mena and is preferentially
expressed in invasive cancer cells. However, determination of the precise mechanistic roles of Mena and
MenaINV in metastatic processes has proven challenging. There is currently no molecular explanation for
differences in the protein-protein interaction properties of Mena and its paralogs/isoforms. Designed
peptide/mini-protein binders can reveal molecular determinants of binding specificity and inspire/inform the
design of lead inhibitors. They can also be used to probe the function of proteins in their cellular context and with
temporal control, providing a direct evaluation of therapeutic potential. The primary goal of this proposal is to
uncover the molecular basis for differences in the protein-interaction properties of Mena and MenaINV,
determine the molecular origin of the binding specificity of an existing mini-protein inhibitor, and use
this information to design and test paralog- and isoform- selective, cell-permeable mini-protein inhibitors
of Mena. This goal will be accomplished by applying an array of biophysical experiments such as NMR, SAXS,
X-ray crystallography and binding assays to uncover the molecular origin of protein-interaction differences
between Mena and its paralogs/isoforms. These experiments will reveal molecular determinants of inhibitor
binding specificity and contribute to our understanding of metastasis by providing a molecular explanation for
differences between Mena and MenaINV. The biophysical information gained from these experiments will then be
incorporated into the design of paralog- and isoform- specific mini-protein inhibitors using cutting-edge protein
design methods, including structure-based computation, focused library design, and high throughput screening
techniques. In addition to training in a variety of new research methods, the training plan outlined here includes
extensive development of scientific communication, responsible conduct of research, scientific networking,
teaching, mentoring and management skills. The research and training will take place in the laboratory of Dr.
Amy Keating, a highly interdisciplinary and collaborative group at the forefront of the protein-protein interaction
and protein design fields. The Keating lab is embedded in the MIT Biology department and part of the Koch
Institute for Integrative Cancer Research, providing an ideal environment for training, collaboration, and research.

Public health relevance
Project Narrative The vast majority of cancer patient deaths are not caused by the initial tumor, but by the cancer spreading to invade distant parts of the body in a process called metastasis. This project investigates fundamental molecular properties that differentiate Mena, a protein integral to metastasis, from other paralogs/isoforms, uncovering the molecular determinants of Mena’s binding specificity and providing a molecular explanation of the differences between Mena and an invasion-associate Mena isoform. Using cutting edge protein design techniques, this information will be incorporated into the design of paralog- and isoform- specific mini-protein inhibitors of Mena that can be used to probe its role in metastasis and evaluate its therapeutic potential.